Language Profiles and Outcomes in School-Age Children Diagnosed with Autism Spectrum Disorder as Toddlers

Project Summary/Abstract
Late language emergence occurs in approximately 10-20% of children. There is significant variability in
language outcomes among late-talking children, further complicated by the heterogeneity of this population,
including children with neurodevelopmental disorders such as Autism Spectrum Disorder (ASD). Our group
recently found that ASD diagnoses do not persist at school age for over one-third of children diagnosed as
toddlers (termed “persistent ASD” and “non-persistent ASD”). Gaps remain in our knowledge about language
outcomes and their predictors in children diagnosed with ASD at a young age, particularly those who no longer
fulfill ASD criteria. Identifying predictors for late-talking children most at risk for persistent language impairment
would strengthen initial counseling recommendations regarding intervention and prognosis. Understanding
domains of language impacted in children with persistent and non-persistent ASD could support clinicians in
monitoring specific language domains, such as language syntax and morphology, during developmental follow-
up visits for children initially diagnosed with ASD.
Thus, we will leverage a unique extant database to characterize language profiles and outcomes in 213
children diagnosed with ASD as toddlers (<36 months) and re-evaluated at school-age (5-7 years). Our
objectives are to: 1) Examine language outcomes in school-age children diagnosed with ASD as toddlers and
identify predictors of language outcomes in these children, and 2) Compare aspects of language as a function
of ASD status (persistent vs. non-persistent) in 5-7 year old children diagnosed with ASD as toddlers.
Our methods will include a latent class analysis based on available data in the extant BOAT database to
identify groups of children based on language function. Latent classes will be formed by variables including
functional communication (Vineland-3), expressive and receptive language (PLS-5), verbal IQ (DAS), and
speech (parent report of speech disorder). We will also analyze predictors of overall class membership,
including baseline cognition, language, and adaptive skills abstracted from an initial clinical evaluation and
persistence of ASD. Finally, we will complete subdomain-level analyses of PLS-5 protocols and language
sampling analysis using Systematic Analysis of Language Transcripts (SALT) to characterize individual aspects
of language/ communication in children who continue to meet diagnostic criteria for ASD vs. those who do not.
This project will address an unmet clinical need to better identify predictors of language outcomes in late-
talking children diagnosed with ASD, characterize language profiles with a focus on functional impairment, and
assess differences in language in children who continue to meet ASD criteria vs. those who do not.

Public health relevance
Project Narrative (2-3 sentences, plain language) The purpose of this research study is to learn about language outcomes in early school-age children who were diagnosed with Autism Spectrum Disorder (ASD) when they were toddlers. Our goal is to understand more about how children talk and communicate and whether we might be able to identify some early predictors of later language challenges. We also want to know if there are differences in aspects of language in children who no longer meet diagnostic criteria for ASD at school age compared with those who still meet criteria.